PHASE RESETTING AND SENSORY INHIBITION IN THE CNS

DESCRIPTION (Adapted from applicant's abstract): Studies outlined in this application propose to examine the role the EEG play in mediating the ability of the brain to inhibit incoming irrelevant sensory input (sensory gating and habituation). The project has a number of specific aims. The investigator's first aim is to provide data supporting the hypothesis that phase resetting of the EEG (phase synchronization) plays an important role in determining the brain's response to novel stimuli. He also plans to show that the failure to phase reset the EEG plays a significant role in allowing the organism to stop responding (or inhibit the response) to repetitive irrelevant stimuli. Providing evidence that both processes are deficient in schizophrenia patients encompasses the investigator's last two goals for this project. Utilizing a fuzzy logic technique (that was developed by this group) evoked potential data containing the P50 mid-latency auditory component will be compared between a group of schizophrenia patients and a group of age- and sex-matched normal controls. Data will be collected at the West Haven Veterans Hospital and will be blindly analyzed in Dr. Jansen's laboratory in Houston. Data provided through this study will shed more light on the physiological mechanisms mediating the protective fundamental function of habituation. Elucidation of abnormalities of this function in schizophrenia patients will increase our understanding of this complex disorder and may contribute to developing more effective diagnostic instruments and therapeutic and rehabilitative interventions.